Heme Homeostasis in the Malaria Parasite Plasmodium falciparum

PROJECT SUMMARY
Malaria is the deadliest vector born disease, responsible for 249 million cases and 608,000 deaths in
2022. Malaria parasites replicate asexually in red blood cells where they digest up to 80% of host hemoglobin
into globin peptides and heme. Heme is an essential cofactor, but is redox active in its free form. Parasites
detoxify the majority of hemoglobin-derived heme by sequestering into inert hemozoin. Heme biosynthesis is
inactive in blood stages, suggesting that blood stage parasites scavenge a portion of hemoglobin-derived heme
for heme-requiring processes. As blood stage parasites mature, hemoglobin digestion increases, yet cytosolic
heme concentrations remain constant at approximately 1.6 µM. How do parasites maintain cytosolic heme
concentrations? To test the hypothesis that Plasmodium utilizes heme binding proteins to maintain heme
homeostasis and that these heme-binding proteins will be essential for parasite viability, two orthogonal
approaches will be taken: one unbiased approach and one directed approach. For the unbiased approach,
parasite heme-binding proteins will be identified using a cutting-edge click-chemistry based method. Tagged
conditional knockdown parasites will be generated to determine essentiality, expression, and localization of
candidate proteins. To assess the involvement of candidate proteins in parasite heme handling, dose response
assays will be used to assess the susceptibility of knockdown parasites to antimalarials that are known to disrupt
heme homeostasis. In addition, heme species will be quantified under wild type and knockdown conditions using
a pyridine-based heme fractionation assay and a genetically encoded heme biosensor. For the direct approach,
the role of Heme Detoxification Protein (PfHDP; PF3D7_1446800) in heme homeostasis will be investigated.
Recombinant PfHDP can bind heme and promote hemozoin formation in vitro. While PfHDP knockdown
parasites have a severe growth defect, these parasites display no discernable defect in hemozoin formation. To
investigate the hypothesis that PfHDP is involved in parasite heme handling independent of hemozoin formation,
it will first be determined if PfHDP binds heme within the parasite basally or when heme homeostasis is disrupted.
Next, sensitivity of PfHDP knockdown parasites will be assessed to quinoline antimalarials that are known to
increase cytosolic heme concentrations. Finally, levels of cytosolic heme, hemozoin, and hemoglobin will be
quantified under wildtype and PfHDP knockdown conditions using the pyridine-based heme fractionation assay
and a genetically encoded heme biosensor. Interfering with heme detoxification has proven an effective
antimalarial strategy. However, resistance to the traditional hemozoin biosynthesis inhibitors has limited their
therapeutic use. Results from the experiments proposed here will provide insight into plasmodial heme
homeostasis mechanisms. These results will reveal novel parasite proteins that can be exploited for future drug
development and may provide insight into novel heme handling mechanisms in other organisms.

Public health relevance
PROJECT NARRATIVE Blood stage malaria parasites encounter enormous amounts of heme and are extremely vulnerable to disruptions in heme homeostasis, yet it remains unknown how parasites regulate cytosolic heme concentrations. Use a cutting-edge click-chemistry-based technique, we will identify previously unknown heme binding proteins and then directly investigate the role of these candidate proteins as well as Heme Detoxification Protein in plasmodial heme homeostasis. Our work will reveal novel antimalarial targets that can be exploited to overcome current problems with antimalarial resistance.